Neuroimaging Phenotypes of Post-Traumatic Epilepsy

Project Summary/Abstract
Dr. James Gugger is an Assistant Professor of Neurology at the University of Pennsylvania with clinical
expertise in both epilepsy and traumatic brain injury (TBI). His long-term goal as a physician-scientist is to use
quantitative neuroimaging to define neurobiologically grounded phenotypes of neurological disorders, which
will improve our understanding of disorders such as epilepsy and TBI and ultimately improve care.
The neurobiological phenotype of TBI involves both focal and diffuse injury mechanisms. Both animal and human
data implicate damage to the limbic network in those with epilepsy after head injury. This proposal tests the
hypothesis that the effects of focal and diffuse injury mechanisms on the limbic network can be used to
distinguish patients with TBI who will develop epilepsy from those who do not. Experiments will utilize
neuroimaging data from a large, well-phenotyped cohort of participants with TBI and uninjured controls. The
specific aims are (1) to define the relationship between focal post-traumatic lesions and brain networks implicated
in post-traumatic epilepsy (PTE) and (2) to determine the profile of diffuse injury in brain networks implicated in
PTE. This project will uncover neuroimaging phenotypes present prior to the onset of PTE and advance us
towards identification of biomarkers for epilepsy risk stratification.
The proposal builds on Dr. Gugger’s prior research on quantitative multimodal neuroimaging in TBI and
epilepsy. With the support of a team of mentors at the University of Pennsylvania who are leaders in the field,
he will gain expertise in functional neuroimaging, statistical modeling of multimodal neuroimaging data, and the
conduct of prospective neuroimaging studies. Dr. Gugger’s team of mentors at the University of Pennsylvania
(Drs. Diaz-Arrastia, Davis, Shinohara, and Detre) have strong track records of mentorship and will provide
specific expertise in his areas of skill development. He will also leverage his existing relationships with large
multicenter consortia focused on PTE research (Transforming Research and Clinical Knowledge in TBI
[TRACK-TBI] Network, Military Injuries—Understanding PTE: Bioinformatics with big data to examine multi-
modal PTE biomarkers [MINUTE], and the Epilepsy Bioinformatics Study for Antiepileptogenic Therapy
[EpiBioS4Rx]) to launch future studies as an independent physician scientist. Dr. Gugger’s clinical background
in epilepsy and TBI, with the additional support of this career development award and his unique mentorship
opportunities, will position him to succeed as an independent physician-scientist focused on using quantitative
neuroimaging to improve the lives of people with epilepsy and TBI.

Public health relevance
Project Narrative Epilepsy is a chronic, debilitating neurological disorder that affects millions of people across the globe. Epilepsy due to head injury, known as post-traumatic epilepsy, represents an opportunity to understand the changes in the brain that lead to epilepsy. This research will help us understand the unique structural and functional changes in the brain leading to post-traumatic epilepsy and develop tools for epilepsy risk stratification after head injury—a prerequisite for feasible clinical trials of therapies for the prevention of epilepsy.